Diet promotes muscle stem cell activation and proliferation in Drsosophila

Project Summary
Muscle stem cells (MuSCs) are critical for neonatal muscle growth, and repair during aging and muscle disease.
These stem cells reside in the vicinity of muscle fibers and stay quiescent under normal conditions. Following
muscle damage due to aging or myopathy these stem cells exit quiescence/undergo activation and proliferation,
to repair the muscle. Defects in MuSC activation and proliferation triggers muscle degeneration in Duchene
muscular dystrophy (DMD), the most common and severe form of muscle disease diagnosed in infants. Impaired
MuSC proliferation is also associated with sarcopenia; an age associated loss of muscle mass and strength. Thus,
MuSC activation and amplification are critical for its regenerative potential and muscle health. Human clinical
studies have highlighted the role of diet in muscle stem cell mediated muscle repair. However, the mechanism
through which this regulation takes place is not clearly understood. In this proposal, we decipher the mechanism
through which diet or diet responsive PI3K/Akt/Tor signaling promotes muscle stem cell activation and proliferation.
Our central hypothesis is that diet positively regulates MuSC activation and proliferation, and this is achieved
through the crosstalk between fat body, wing disc niche (MuSC microenvironment) and MuSC. We will test our
hypothesis in the following specific aims. Aim 1: Determine how the disruption of PI3K/Akt/Tor signaling in MuSC
reduces MuSC pool, muscle growth and function. Aim 2: Decipher the mechanism through which amino acid free
diet inhibits MuSC activation and proliferation. Aim 3: Dissect the signaling network that interacts with Akt to amplify
MuSC pool and muscle size. The results of this study will provide new insights likely relevant to understand how
diet influences MuSC activation/proliferation to promote muscle growth and regeneration during aging and muscle
disease in mammals. Our proposed study will identify key components/pathways that may have a role in muscle
repair during aging. The SuRE-First grant will provide the required resources and training to approximately 36
undergraduates and 8 graduate students including students from underrepresented minority backgrounds at San
Jose State University. The proposed research is student-centered and designed to train students at various
educational levels. Most of the proposed study will be performed by undergraduate students under the supervision
of the graduate students and PI. The trained senior undergraduate students in the laboratory will train new students,
creating a mentoring and learning model that will be implemented for current and future students. This funding will
help the PI to continue working towards solving the important scientific problem that impacts human health, provide
valuable research training to the students and contribute to the learning environment at San Jose State University.

Public health relevance
Project Narrative Clinical studies have shown that diet influences muscle stem cell mediated muscle growth, repair and regeneration during aging and myopathies, but the mechanisms through which this regulation takes place are poorly understood. The proposed research genetically dissects how diet positively regulates muscle stem cell activation and proliferation to promote muscle growth in Drosophila. Given the fundamental similarities between Drosophila and human muscle stem cells the proposed study will provide us novel insights towards developing new non-invasive dietary intervention strategies for improving muscle health in humans.